CLINICAL INVESTIGATIONS CORE

PROJECT SUMMARY (See instructions): Objective: The Clinical Investigations Core Shared Resource (CICSRSR) supports the

Public health relevance
RELEVANCE (See instructions): The Clinical Investigations Core Shared Resource (CICSRSR) provides support to clinical investigators on all activities related to the successful conduct of clinical trial research. This is the cornerstone to translate basic science knowledge of the cancer process into clinically useful treatments for patients.